Administrative Core

PROJECT SUMMARY/ABSTRACT
The Administrative Core (Core A) has fulfilled three major functions during the current grant, and will
continue to do so in this renewal. One function is the overall management of the P01, which is the
responsibility of the PI, Steven Balk, with an administrator and in consultation with the other PIs. This includes
addressing all administrative issues, organizing group meetings, organizing internal and external reviews,
and in general facilitating communications and collaborations. The second function of the Core has been to
assist the Projects in efforts to ensure that their laboratory studies and findings are physiologically significant,
and ultimately to translate their findings into patients. This has been facilitated by close interactions with our
clinicians, represented by our internal advisory board. Through previous/ongoing clinical trials and tissue
banking efforts at their respective institutions, these clinical investigators have collected (and continue to
collect) valuable samples from patients at varying stages of their disease and after varying therapies. In
discussions with the Project Leaders, they have provided relevant clinical samples for analysis and have
provided further insight into potential biological significance of laboratory findings. The third Core function is
to provide statistical support for each of the Project Leaders in their experimental designs. The Specific Aims
are 1) Provide administrative support to insure that the goals of the project are achieved, 2) Assist in
translating the results from each Project into the clinic, 3) Provide biostatistical support for each Project.

Public health relevance
PROJECT NARRATIVE The Administrative Core (Core A) is responsible for the overall management of the P01, including addressing all administrative issues, organizing group meetings, organizing internal and external reviews, and in general facilitating communications and collaborations. The second function of the Core is to assist the Projects in efforts to ensure that their laboratory studies and findings are physiologically significant, and ultimately to translate their findings into patients. The third Core function is to provide statistical support for each of the Project Leaders in their experimental designs.